Regulation of Alcohol-induced Fatty Liver Disease by Lipid Droplet Trafficking

DESCRIPTION (provided by applicant): This application addresses broad Challenge Area (11): Regenerative Medicine and specific Challenge Topic 11-AA-102: Roles of Cellular Organelles and the Cytoskeleton in Alcohol-induced Organ Damage. Alcohol abuse and alcohol-induced liver disease are a major health concern in the US and worldwide. Alcoholic fatty liver disease (AFLD) is marked by the aberrant accumulation of intracellular fatty acids in hepatocytes and can progress to hepatitis, fibrosis, cirrhosis, and liver failure. Steatosis, the accumulation of fat in hepatocytes, is the reversible initial step of AFLD. As such, it is a prime target for therapeutic intervention to block AFLD progression. Intracellular lipids are stored in hepatocytes in lipid droplets, dynamic organelles that accumulate in excess in steatosis. However, the formation, regulation, and metabolism of lipid droplets are poorly understood. This proposal will focus on defining the mechanisms of lipid droplet trafficking, their interaction with other central intracellular organelles and how these processes are altered under conditions of ethanol exposure. Our central hypothesis is that chronic ethanol exposure alters the normal vesicle trafficking between lipid droplets and other membrane organelles in the hepatocyte, leading to fatty liver. The endoplasmic reticulum (ER), Golgi apparatus, and endosomal compartments have all been linked to lipid droplets. Two different laboratories expert in alcohol induced liver damage and hepatocellular membrane-cytoskeletal dynamics will work in synergy to determine the functions of each of these organelles in regulating lipid droplet formation and metabolism under normal conditions and following ethanol exposure to mediate the progression of AFLD. PUBLIC HEALTH RELEVANCE: The goal of this proposal is to examine how impairments and alterations in trafficking and targeting of lipid droplets (LD) to specific organelles influences LD accumulation in steatosis and contributes to alcohol-induced fatty liver disease (AFLD). We hypothesize that chronic ethanol exposure alters the normal vesicle trafficking between lipid droplets and Golgi, endosomes, and endoplasmic reticulum, leading to fatty liver and subsequently hepatocellular damage. Successful completion of these studies will provide information which could lead to therapeutic strategies that might reduce the severity of steatosis and block the further progression to steatohepatitis, fibrosis and cirrhosis

Public health relevance
Project Narrative: The goal of this proposal is to examine how impairments and alterations in trafficking and targeting of lipid droplets (LD) to specific organelles influences LD accumulation in steatosis and contributes to alcohol-induced fatty liver disease (AFLD). We hypothesize that chronic ethanol exposure alters the normal vesicle trafficking between lipid droplets and Golgi, endosomes, and endoplasmic reticulum, leading to fatty liver and subsequently hepatocellular damage. Successful completion of these studies will provide information which could lead to therapeutic strategies that might reduce the severity of steatosis and block the further progression to steatohepatitis, fibrosis and cirrhosis